Depleting exosomes to improve responses to immune therapy in HNSCC

PROJECT SUMMARY/ABSTRACT
Patients with head and neck squamous cell cancer (HNSCC) continue to have poor prognosis, largely because
of disease recurrence and/or the development of metastatic disease. New therapies are an unmet need for
patients with recurrent/metastatic HNSCC. Immune-based therapies, including immune checkpoint inhibitors
(ICIs), have been introduced and Pembrolizumab, an anti-PD-1 monoclonal antibody, is currently approved by
the US Food and Drug Administration (FDA) for the first-line treatment of patients with unresectable
recurrent/metastatic HNSCC. Use of ICIs is based on the premise that rejuvenation of suppressed anti-tumor
immunity in cancer patients will improve outcome. Unfortunately, only a minority of the HNSCC patients treated
with ICIs responds to the immunotherapy (IT), possibly due to the unresponsiveness of immune cells to activation
in profoundly immunosuppressed HNSCC patients. Exosomes have emerged as major contributors to tumor-
associated immune suppression and a significant barrier to antibody-based and adoptive cell-based therapies
in cancer. We have reported that IT is not effective in cancer patients with high levels of circulating exosomes,
and have also shown that circulating exosomes carrying immunosuppressive ligands, such as PD-L1, impair
functions of immune effector cells in HNSCC patients and negatively impact disease progression. Therefore, we
hypothesize that the removal of immunosuppressive exosomes from the circulation of HNSCC patients prior to
IT will promote immune cell recovery and significantly increase the response rate. To test this hypothesis and
develop novel therapeutic capabilities for cancer patients, we have established a partnership between Aethlon
Medical, Inc. and three academic institutions. Aethlon Medical, Inc. has developed the Hemopurifier®, a good
manufacturing practices (GMP)-compatible device for removal of blood-borne viruses and exosomes and
designed for use with standard dialysis machines. In Aim 1, we will characterize exosomes removed from
HNSCC patients’ plasma by the research-grade version of the Hemopurifier. We will correlate the
immunosuppressive profiles, functions and miRNA content of these exosomes with clinicopathological endpoints
and disease activity. In addition, using a mouse model, we will demonstrate that depletion of exosomes restores
anti-tumor immunity and inhibits tumor growth, while delivery of suppressive exosomes promotes tumor growth
and carcinogenesis. In Aim 2, we will conduct a single-arm Phase II clinical trial using a clinical-grade
Hemopurifier to establish that removal of exosomes from the circulation of patients with recurrent/metastatic
HNSCC improves responses to IT. Finally, in Aim 3, we will utilize data and samples from the Phase II clinical
trial to identify predictors of benefit from exosome depletion by Hemopurifier prior to IT. Successful completion
of the proposed project is expected to result in novel therapeutic capabilities and new predictive tools based on
plasma exosomes to improve clinical responses to ITs for patients with HNSCC.

Public health relevance
PROJECT NARRATIVE This project is a collaboration between three academic institutions and Aethlon Medical, Inc. The overarching objective is to improve response to immunotherapy by removing immunosuppressive exosomes from the circulation of patients with head and neck squamous cell cancer (HNSCC). Aethlon Medical, Inc. has developed a GMP-compatible device to remove circulating exosomes, the Hemopurifier. We will use the Hemopurifier to show that removal of exosomes from HNSCC patients’ blood prior to immunotherapy will promote immune cell recovery and significantly increase the response rate.